Fluid shear stress mechanotransduction at endothelial cell-cell junctions

Summary of the funded parent grant
The goal of our project “Fluid shear stress mechanotransduction at endothelial cell-cell junctions” is to
elucidate mechanisms by which vascular endothelial cells sense fluid shear stress (FSS) from blood flow,
which is a major determinant of blood vessel embryonic development, adult physiology and multiple diseases
including atherosclerosis and vascular malformations. While a great many pathways and genes that respond to
FSS have been identified, major questions about fundamental molecular mechanisms by which cell convert
FSS into biochemical information remain unanswered. The project is based on published and preliminary data
showing that cell-cell junctions are a major site of shear stress mechanotransduction via a complex of
membrane proteins consisting of the homophilic adhesion receptors PECAM-1 (hereafter PECAM) and VE-
cadherin, and the receptor tyrosine kinases VEGF receptor 2 and 3. More recently, we have identified the
adhesion GPCR latrophilin1 (ADGRL2) as another junctional protein that appears to be the initial upstream
trigger that activates the junctional pathway [1]. This pathway is highly relevant to vascular disease as
polymorphisms in PECAM-1 are linked to atherosclerosis, while ADGRL2 is linked to hypertension and
ischemic stroke.

Public health relevance
Narrative We are requesting funding for an African American PhD candidate to study the role of the polarity protein LGN in fluid shear stress mechanotransduction in vascular endothelial cells. The proposed experiments will encompass both mechanistic structure-function analyses and investigation of function in LGN-null mice. Educational aspects include in-lab training and mentorship, workshops and short courses to learn additional methods, and attendance at national and international meetings.